Development of a minimally invasive biomarker assay to detect delayed radiation injury

PROJECT SUMMARY/ABSTRACT
The general population continues to be at risk of exposure to ionizing radiation because of nuclear warfare,
terrorism, or radiological accidents. Some countermeasures of the acute radiation syndrome (ARS) have been
placed in the national stockpile, increasing the chance of survival in a radiation emergency. However, individuals
who survive the ARS may develop delayed effects of acute radiation exposure (DEARE) within months to years
after irradiation. Currently, no system is available for the early identification of individuals who are at risk for
DEARE and in which particular organ systems late radiation injuries will occur. Therefore, to personalize the
clinical management of radiation victims, research is required to develop minimally invasive assays that predict
organ-specific DEARE. However, although ~25% of the total population is pediatric, to our knowledge, no
research has been performed in predictive biomarker assays of DEARE in victims who have been exposed at a
young age. The main goal of the NIAID funded grant U01 AI148308 “Development of a minimally invasive
biomarker assay to detect delayed radiation injury” is to develop urine and plasma biomarker assays of radiation
injury to major organ systems at risk. In this parent project, the initial identification of urine and plasma biomarkers
is performed with untargeted high-resolution mass spectrometry-based metabolomics in adult male and female
WAG/RijCmcr rats (11-12 weeks of age) exposed to X-rays (0, 6, 9.5 and 13 Gy) with one hind-leg shielded from
radiation to assure long-term survival of the animals. In years 1 and 2 of the parent U01 grant, we received
supplements to perform studies in a juvenile rat model of leg-out X-ray exposure, to identify early biomarker
panels that predict the development of lung, kidney and heart radiation injury. We exposed 41-44 days old male
and female WAG/RijCmcr rats to a single dose of 12 Gy, 13 Gy (males), or 13.5 Gy (females). These radiation
exposures resulted in radiation pneumonitis and kidney dysfunction within the first 160 days after irradiation.
However, long-term kidney and heart injury could not be studied. Therefore, in this supplement application, we
propose to expose female WAG/RijCmcr rats at the age of 41-44 days to 9.5 Gy leg-out X-rays. Based on our
experience with adult rats, we expect that all animals will survive long-term, which will allow us to examine both
kidney and cardiac dysfunction. This radiation dose will then complete a dose response study of DEARE in our
juvenile rat model. Moreover, we propose to treat a subcohort of rats with the FDA-approved radiation
countermeasure Neulasta, to examine its effects on DEARE as well as predictive biomarkers. We will use the
same rat strain and metabolomics/lipidomics approaches as in the parent U01, which will enable us to make
comparisons of biomarker panels in juvenile and adult rats.

Public health relevance
NARRATIVE In view of the ongoing threat of mass casualties due to radiological accidents or nuclear terrorism, noninvasive biomarkers that predict the development of delayed injuries in both young and adult radiation exposed victims are required. The proposed project makes use of a juvenile rat model to identify plasma and urine biomarkers that predict the development of radiation injury in the kidney and heart of female rats exposed to radiation at a young age. Knowledge obtained from this work will aid in developing tools for the prediction of organ-specific injuries in pediatric victims of radiation exposure.